Autophagy in liver injury

PROJECT SUMMARY/ABSTRACT
Ischemia/reperfusion (I/R) injury in the liver occurs during liver resection and transplantation. Steatotic livers are
highly susceptible to I/R injury than lean livers. No therapeutic strategies are currently available to attenuate I/R
injury in the patients with steatotic livers. mitoNEET (mNT) is an evolutionarily conserved mitochondrial outer
membrane protein containing a unique 2Fe-2S cluster that is tetrahedrally coordinated by 3 Cysteine and 1
Histidine. This small mitochondrial protein regulates redox, bioenergetics, iron homeostasis and autophagy, all
of which are indispensable in liver survival after I/R. It is unknown how hepatic mNT is affected by steatosis and
I/R. In this application, we will test the hypothesis that the accumulation of nonfunctional mNT sensitizes steatotic
livers to I/R injury. Here we have the three independent but complementary Aims. In Aim 1, we will use mouse
hepatocytes to investigate molecular mechanisms behind heightened I/R injury in steatotic livers. In Aim 2, we
will extend in vitro findings from isolated mouse hepatocytes to an in vivo model of mouse hepatic I/R. In Aim 3,
using discarded human livers, we will investigate molecular mechanisms and test the efficacy and safety of
potential therapeutic strategies.

Public health relevance
PROJECT NARRATIVE Ischemia/reperfusion (I/R) injury is a causative factor of morbidity and mortality during liver resection, and transplantation. Steatotic livers has significantly more vulnerable to I/R injury associated with these operations. There are no therapeutic strategies to reduce this I/R injury in steatotic livers. Therefore, our goal of this proposal is to develop novel therapeutic strategies to attenuate I/R injury in steatotic livers.